Development of a Novel Therapeutic for Mitigating Radiation-Induced Microbiome Dysbiosis and Acute Gastrointestinal Syndrome

SUMMARY
A mass casualty radiation event, such as the detonation of an improvised nuclear device or radiological dispersal
device, could lead to severe hemorrhage, multi-organ failure, and infection, potentially leading to sepsis and/or
death. The hematopoietic system and the gastrointestinal (GI) tract are among the most vulnerable tissues to
radiation injury. High-dose radiation results in GI syndrome characterized by microbiome dysbiosis, destruction
of mucosal layer, intestinal epithelial barrier dysfunction, and aberrant inflammatory responses that initiate a
vicious cycle of further GI tract damage that can lead to rapid death. Although progress has been made to
counteract the immediate effects of hematopoietic acute radiation syndrome, no FDA-approved
countermeasures exist that can treat radiation-induced GI injury. To meet this critical need, Synedgen Inc., has
developed a glycopolymer radiomitigator (MIIST305) that is specifically targeted to the GI tract that could
potentially ameliorate the deleterious effects of radiation. The therapeutic drug has been shown to reduce cell
death, suppress local and systemic inflammation, and improve tissue regeneration in models associated with
inflammatory bowel disease. Our preliminary studies have shown that MIIST305 confers significant survival to
mice exposed to high-dose partial body x-irradiation, when administered 24 hours post-irradiation. Furthermore,
MIIST305 appears to promote pro-inflammatory resolution and maintain more normal gut microbiota composition
in response to GI injury. We hypothesize that MIIST305 maintains the integrity of the mucosal layer thus
preserving a healthy microbiome in response to irradiation, minimizing disruption of intestinal epithelial barrier
function and alleviating inflammation. To test this hypothesis, we propose two specific aims. In Aim 1, we will
perform longitudinal structural and functional studies to determine the impact of acute dose, partial body
irradiation with 5% bone marrow sparing on GI architectural integrity, commensal gut microbiota composition
and diversity, and inflammation compared to MIIST305-mitigated animals. In Aim 2, we will define the importance
of MIIST305-regulated commensal microbiota composition and elucidate the molecular pathways leading to
MIIST305 suppression of the pro-inflammatory response and ultimately, mitigation of radiation-induced toxicity,
using both transgenic mouse models and cell-based assays. To address the overarching goals of this funding
announcement, we propose to (a) explore how the microbiome affects severity of radiation injury, (b) develop
novel countermeasures against radiation-induced GI damage with efficacy starting 24 hours after radiation
exposure, and (c) define the mechanism of action of the countermeasures, which will provide the necessary
information for FDA approval under the Animal Rule.

Public health relevance
PROJECT NARRATIVE Currently, there are no FDA-approved drugs that can counteract GI acute radiation syndrome characterized by microbiome dysbiosis, destruction of mucosal layer, intestinal epithelial barrier dysfunction, and severe inflammation that can lead to rapid death. MIIST305 is a novel GI-targeted therapeutic that greatly enhances survival in mice exposed to lethal radiation and protects the GI tract from injury by maintaining a balanced gut microbiota and effectively reducing proinflammatory responses. Further development of this drug as an FDA- approved medical countermeasure will be of critical importance in the event of a radiation public health emergency.